Mapping and Prediction of Epistatic Enhancer Interactions in Gene Regulation

Project Summary
Gene regulation is a fundamental biological process through which noncoding regulatory elements work
interactively in a holistic model to determine traits and diseases. Regulatory elements (e.g., enhancers) recruit
transcriptional factors (TFs) collectively and explicitly control gene expression to define phenotypic states. The
epistatic interaction, in which the function of one enhancer depends on the presence or absence of another
enhancer, has been recognized as fundamentally important to understand the complexity of gene regulation.
Elucidating the principles of how enhancers coordinate to control gene transcription, and the TFs they
utilize to get there, is a major challenge in the field. Perturbing combinatorial enhancers and measuring their
epistatic effects on the gene regulatory contributions to traits and diseases is necessary. Recent advances in
CRISPR-based genome engineering technologies have enabled new approaches for the multiplexed
perturbation of regulatory elements. We recently demonstrated that multiplexed CRISPR interference (CRISPRi)
systems enable the robust and accurate interrogation of the function of enhancer epistasis networks in gene
regulation. Furthermore, the emergence of new technologies and datasets, including single-cell RNA sequencing,
non-linear deep learning models, and large-scale genome-wide association studies (GWAS) datasets, provides
unprecedented opportunities to uncover the mechanisms underlying enhancer epistatic interactions and how
they relate to gene expression. My research program aims to exploit this enormous potential by developing
analytic approaches that probe the enhancer epistatic interactions in gene regulation and model the interactive
consequence of noncoding variants for functionality and ultimately pathogenicity. We will (i) map the epistatic
interactions by establishing best practices in multiplexed perturbation assay design and analysis; (ii) dissect how
inter-molecular TF interactions determine enhancer epistasis; (iii) develop novel mechanistic computational
approaches to predict the functional consequence of interactive enhancer variants. Our studies will lead to novel
insights into fully understanding the regulatory complexity that controls the expression of human genes. They
will shift the paradigm in the interpretation of millions of noncoding disease variants from a locus-by-locus model
to an epistasis-aware model. We anticipate that ability will be particularly powerful for translating genetic
associations into disease mechanisms, thus creating a windfall of new knowledge about how genomic regulatory
elements contribute to disease, and how to monitor and manipulate enhancers for diagnostic and therapeutic
benefit.
1

Public health relevance
Project Narrative Interaction is a fundamental process in gene regulation, enabling millions of DNA elements to coordinate and maintain precise gene expression levels necessary for the development of distinct cell types. This proposed project seeks to elucidate the underlying mechanisms of DNA element interactions, thereby enhancing our understanding of how genetic variants in these elements carried by individuals interactively influence physical traits and disease susceptibility. Using CRISPR-based multiplexed perturbation technologies and deep learning modes, we aim to uncover common biological principles governing DNA element interactions in gene regulation and, ultimately, their role in disease pathogenesis. 2